Specific-sized hyaluronan: a dual targeted therapy for ALD

ABSTRACT
Alcoholic liver disease (ALD) develops in approximately 20% of alcoholics. The development of ALD is a complex
process involving both parenchymal and non-parenchymal cells in the liver, as well as recruitment of immune cells
in response to damage and inflammation. Innate immunity and inter-organ cross talk contribute to ethanol-
induced liver injury with interactions between intestine and liver of particular importance. Impaired intestinal
barrier function is associated with ethanol-induced liver injury in both humans and rodent models. Increased
exposure of Kupffer cells, the resident hepatic macrophages, to gut-derived LPS during chronic ethanol
activates TLR4-dependent production of inflammatory mediators. Chronic ethanol exposure also sensitizes
Kupffer cells to LPS, resulting in increased production of inflammatory mediators. Hyaluronan (HA), an abundant
extracellular matrix component, communicates with cells in a size-specific manner. Specific-sized HA
fragments are either pro-inflammatory or anti-inflammatory, depending on the HA receptor and cell type involved
in the response. We have discovered that specific-sized HA35 (average MW~35kD) normalizes TLR4-
mediated signaling in Kupffer cells after chronic ethanol exposure and also protects mice from ethanol-
induced gut and liver injury. By Next Generation Sequencing, we have identified a subset of microRNAs that
are reciprocally regulated by HA35, providing novel insights into the mechanism of action for both ethanol and
HA35 in regulating TLR4 signaling and macrophage polarization Furthermore, our team finds that specific-sized
HA35 promotes intestinal health, at least in part by increasing expression of β-defensins and promoting the
formation of tight junctions. Based on the multi-potent functions of HA35, here we will test the hypothesis that
HA35 is a dually targeted therapeutic agent in ALD, normalizing Kupffer cell signal transduction after chronic
ethanol exposure and protecting the intestinal epithelial barrier. We will address this hypothesis in three Specific
Aims. Specific Aim 1: Investigate the mechanism for normalization of TLR4 signaling by HA35 in rat Kupffer
cells and human PBMCs. Making use of both bioinformatics and cell based assays, we will 1) investigate the
miRNA regulatory pathways reciprocally targeted by ethanol and HA35, which in turn regulate a) the control of
nuclear-cytoplasmic shuttling and b) macrophage polarization. Specific Aim 2: Interrogate the impact of HA35
on maintenance of intestinal barrier function. We will use both cultured Caco-2 cells and mouse intestinal
organoids to determine mechanisms for the direct effect of HA35 on protecting tight junctions from ethanol.
Specific Aim 3: Test the ability of HA35 to prevent and treat chronic ethanol-induced intestinal and liver injury
in mice. Importantly, medical grade HA for device-use is commercially available, thus enhancing the
likelihood for a rapid translation of our studies on the dually protective functions of HA35 in chronic ethanol
exposure into clinical investigations in ALD.

Public health relevance
PROJECT NARRATIVE Alcohol abuse is a leading cause of morbidity and mortality worldwide and recent data indicate that alcoholic liver disease affects over 10 million Americans. The long-term goals of this research project are to identify therapeutic agents that will prevent ethanol-induced injury to intestine and liver. Previous work has identified inflammatory responses as critical contributors to disease progression; however, we do not yet understand how ethanol increases inflammation, nor how to normalize ethanol-induced inflammation that ultimately leads to alcoholic liver disease. Increased intestinal permeability and changes in bacterial microflora result in elevated levels of bacterial products in alcoholic patients and animal models of ALD. Lipopolysaccharide (LPS) recognition by Toll-like receptor 4 (TLR4) on Kupffer cells, the resident hepatic macrophages, releases inflammatory cytokines that impact the functions of hepatocytes and stellate cells. We have recently discovered that a small specific sized hyaluronic acid (HA35) can normalize TLR4 signaling in Kupffer cells from ethanol-fed rats and also protect mice from short term ethanol-induced injury to both the intestine and the liver. Here we will determine the mechanisms for these protective effects of HA35 in macrophages and intestine, as well as determine its efficacy in preventing and treating chronic, severe ethanol-induced injury to liver and intestine.